Center of Comparative Medicine and Pathology

ABSTRACT
The Center of Comparative Medicine and Pathology (CCMP) supports animal model use in cancer research
through its Research Animal Resource Center (RARC) and Laboratory of Comparative Pathology (LCP). At
MSK, animal models are used in basic and applied investigational studies as well as for training of
both clinical and research staff. Animals are employed in a various areas including the development of new
methods for diagnosis and treatment of cancer as well as the elucidation of the basic biological mechanisms
resulting in neoplasia. CCMP’s professional and paraprofessional staff (152 FTE) serve as a
consultative and technical resource for MSK investigators on all matters related to animal research.
RARC comprises five sections: 1) Husbandry and Operations (H&O); 2) Veterinary Services (VS); 3)
Education and Quality Assurance (EQA); 4) Specialized Services (SS) consisting of Colony
Management, Aquatics Systems and Services, and Gnotobiotics; and, 5) Biosecurity. RARC provides
housing for and humane care to ~ 150,000 animals daily, utilized by over 130 investigators. RARC’s
oversight of MSK’s AAALAC-accredited, centrally managed animal care program ensures the efficient use of
available space and staff resources and allows for close professional monitoring of the animal research
program. Aquatic Systems and Services maintain the housing systems and provide husbandry and
technical services in support of MSK’s zebrafish colonies. Biosecurity ensures that MSK’s rodent colonies
remain pathogen free by routinely surveying colony health and quarantining incoming rodents from
vendors. EQA administers an extensive educational program that provides training to animal care and
research staff via didactic and hands-on sessions, web-based tutorials, as well as written instructional
materials. RARC’s H&O section operates two specialized state-of-the-art facilities encompassing ~73,700
net square feet of space that provide critical environments and the specialized equipment necessary for the
maintenance and use of a variety of animal models. VS’s staff ensures that all animals receive appropriate
clinical care and perform technical procedures for research staff. The LCP, a multi-disciplinary pathology
laboratory, and its Genetically Engineered Animal (GEA) Phenotyping Service, support individual
laboratory’s research and RARC’s programs by providing clinical and anatomic pathology services and
extensive phenotypic profiles of GEA.